1/2 Milrinone for Prevention of Post-Patent Ductus Arteriosus Closure Syndrome in Extremely Preterm Infants (MIDAS Trial) – CCC

PROJECT SUMMARY
Significance: Prematurity a major health problem in the United States, with more than 385,000 babies born
preterm annually. The economic cost is more than $50 billion, mostly in extremely low birth weight infants
(ELBW, born<1000g). Patent ductus arteriosus (PDA) is the most common cardiovascular problem and
requires interventional closure in 16% of cases. Intervention is complicated by Post-Ligation Cardiac Syndrome
(PLCS), characterized by low or high blood pressure and respiratory instability, with highest incidence in the
most immature patients. Both PDA surgery and PLCS are independently associated with increased risk of
adverse respiratory outcomes and neuro-developmental disabilities. Of surviving ELBW infants after PDA
closure, 50% had neurodevelopmental impairment including severe handicaps. Postprocedural instability is
decreased by early milrinone use, a vasodilator drug which enhances heart function. Avoiding postprocedural
instability and establishing the safety of milrinone are considered important outcomes by parents.
Investigators and Prior Work: Prospective observational mechanistic data demonstrates that PLCS relates to
inability of the immature myocardium to tolerate the change in left ventricular loading conditions. Preliminary
data demonstrates the efficacy of milrinone in reducing the incidence of PLCS through optimizing heart
function. The Clinical Coordinating Center MPI Dr. Patrick McNamara, a world leading hemodynamics
scientist, conducted the original mechanistic studies which characterized the biological mechanisms of PLCS
and the pharmacology of milrinone. Dr Edward Bell (MPI) has an extensive record in leading multicenter
clinical trials and the Data Coordinating Center (DCC) PI Dr. Abhik Das has led several NHLBI funded trials.
Innovation: In most centers PLCS is recognized late, when hypotension is severe, and prompts use of
vasopressor drugs which impair heart function. There are no prior randomized clinical trials of milrinone after
PDA closure; therefore, neither treatment efficacy nor long-term safety is known. We propose a randomized
controlled trial (RCT) to evaluate the immediate benefits of milrinone in decreasing the rate of PLCS and 7-day
mortality. The need to assess long-term outcomes of RCTs is compelling to ensure treatment safety.
Approach: We will perform a RCT in preterm infants born less than 28 weeks’ gestation asking: “Does routine
use of intravenous milrinone lower the risk of PLCS or mortality within 7 days of intervention and is treatment
safe?” The question is relevant to the mission of NHLBI and aligns with parental values to minimize
postprocedural risk. In addition, it represents a paradigm shift in Neonatology to conduct clinical trials of
treatments that offer biologic plausibility in illnesses that have been mechanistically characterized.
Environment: We have partnered with the NICHD Neonatal Research Network (NRN), which includes 15
clinical centers, and have added 4 additional sites to maximize enrollment capabilities. We believe this trial is
both feasible and achievable based on the prior track record of NRN in completing meaningful clinical trials.

Public health relevance
Narrative PDA ligation is a life-saving intervention for some extremely preterm infants but is associated with severe post- interventional cardiorespiratory instability [Post-Ligation Cardiac Syndrome (PLCS)] due to impaired heart function, which may lead to death, bronchopulmonary dysplasia, or neurodevelopmental impairment at 2 years of age. In many centers PLCS is recognized late, when hypotension is severe, prompting use of harmful vasopressor drugs (increase afterload); however, preliminary evidence suggests that prophylactic use of intravenous milrinone (decrease afterload) decreases the risk of PLCS. This randomized trial is designed to evaluate whether a preemptive approach to milrinone treatment will reduce the risk of death or postinterventional cardiorespiratory deterioration. By mitigating the risk of PLCS, patients will require have decreased duration of postinterventional ventilation, and decreased risk of bronchopulmonary dysplasia and adverse neurodevelopmental outcome. Of note, this trial will be the first and only randomized trial of milrinone in premature infants to appraise both short and long-term treatment safety.